STRUCTURE OF CARCINOGEN/NUCLEIC ACID COMPLEXES

The structure of oligodeoxynucleotides modified by the environmental carcinogens benzo(a)pyrene diol epoxide and the carcinogens N-2-(acetylamino)fluorene and N2-(amino)fluorene will be determined by the use of two-dimensional NMR spectroscopy. The distances obtained from NOESY data will be used as restraints in molecular mechanics and molecular dynamics calculations. The three dimensional structures of adducts bound to different sequences will be determined to elucidate the effect of sequence on the structure and dynamics of the adducts. Carcinogen-modified oligodeoxynucleotides will be synthesized containing either codon 12 or codon 61 sequences of the mouse and human c-Ha-ras 1 protooncogenes and the structures determined with covalently attached carcinogens at the guanines which are mutated in activating the oncogenes.